Let's Talk: Overcoming barriers to the uptake of cascade screening through a stakeholder-informed online intervention

ABSTRACT
The impact of genetic testing for disease prevention hinges on cascade screening, the process of
systematically identifying and testing relatives in families with a genetic condition. Lynch syndrome is a
genetic condition that confers an increased lifetime risk of cancer. Unfortunately, only half of first-degree family
members with Lynch syndrome receive cascade screening, representing a missed opportunity in cancer
prevention. Let's Talk is a novel intervention to promote and support cascade screening in families with Lynch
syndrome. Developed using intervention mapping, a 6-step, stakeholder-engaged methodology for developing
theory-based interventions, the workbook intervention addresses barriers to cascade screening through
information chunking, guided practice, planning coping responses, and gain frame messaging for patients, their
provider and family. Preliminary data have demonstrated that the content of Let's Talk, in a paper-based
format, is acceptable to patients with Lynch syndrome, and all patients reported that they would recommend its
use to someone recently diagnosed with Lynch syndrome. In addition, all patients in our usability study
endorsed the development of an interactive, online version, which could improve dissemination, given changes
in genetic counseling workflows due to COVID-19, and could facilitate ongoing patient support through follow-
up messaging. Thus, the overall objective of this project is to (1) adapt and refine an interactive online format
for Let's Talk based on patient preferences and user feedback, and (2) pilot test Let's Talk to assess its
feasibility by measuring implementation (primary) and effectiveness outcomes. The expected outcomes of this
project will move the field forward in tackling challenges associated with cascade screening in Lynch syndrome
and other hereditary conditions. This work will provide foundational data for a future R01 application to test the
effectiveness and implementation of Let's Talk for increasing cascade screening uptake and identification of
relatives with Lynch syndrome across diverse care settings.

Public health relevance
PROJECT NARRATIVE We will adapt and assess the feasibility of an interactive, online version of an intervention, Let's Talk, to improve cascade screening for Lynch syndrome. The expected outcomes of this project will move the field forward in tackling challenges associated with cascade screening. These data can inform future work to increase cascade screening uptake and identification of individuals with Lynch syndrome across diverse care settings and with other genetic conditions.